Stanford Vision Training Program

PROJECT SUMMARY
This program will renew the NEI T32 Stanford Vision Training Program. Based on excellence in postdoctoral
training among our vision science faculty, our goal is to provide a vision-specific research training program
with integrated clinical experience to the talented trainees aiming for careers as vision scientists and
clinician-scientists. Specifically, we seek training support for 4 postdoctoral fellow slots per budget year for
the next five years. The 38 primary vision research faculty in the Stanford Vision Training Program includes
21 PhDs, 4 MDs, and 13 MD/PhDs of all academic ranks, with strengths in diverse areas, including
molecular and cellular vision biology, vision encoding and circuitry, development and genetics, in vivo
imaging, higher order visual behavior and perception, mechanisms of diseases, and different approaches
to the treatment of diseases. Together, the core vision faculty is currently funded by 140 grants totaling over
$36M annually, of which 38 grants are from the NEI, 60 grants are from the NIH (including NEI), and the rest are
from the Department of Defense, National Science Foundation, and various foundations. These are
supplements with strong institutional support and commitment. Following the success from our first program
cycle, developments to strengthen the next cycle of the Stanford Vision Training Program include
leveraging the Stanford Ophthalmology Advanced Research Residency Program and enhancing our Executive
Committee, External Advisory Committee, and Trainee Mentoring Committees. Efforts will continue towards
the recruitment of a highly skilled cohort of vision research faculty to Stanford; unparalleled institutional
resources committed by the department and by the Stanford University School of Medicine; formal
classroom, clinical and laboratory training under the auspices of carefully crafted training plans; and ongoing
semi-monthly and annual vision research symposia. Together with a consistently large, productive and diverse
applicant pool, these will allow the Stanford Vision Training Program to produce future leaders in eye and
vision research who are able to tackle the most interesting and important questions and open new horizons
at Stanford and beyond.

Public health relevance
PROJECT NARRATIVE This renewal of the T32 Stanford Vision Training Program will continue to fund a premier postdoctoral training program designed to integrate excellence in basic vision research and clinical ophthalmologic training. Our explicit goal is to produce investigators capable of using basic research to answer clinically relevant questions. Program components include rigorous research programs with vision faculty of the highest caliber, vision research community events, comprehensive eye and vision courses, and clinical ophthalmologic exposure to facilitate future bench-to-bedside applications of basic vision research.